Western Neurotrauma Symposium

PROJECT SUMMARY/ABSTRACT
Traumatic brain injury (TBI) is one of the top causes of death and disability worldwide. However, due to its
complexity, it remains one of the most challenging neurological conditions to treat. Advances in our
understanding of TBI pathobiology and improvements in clinical care for TBI require multidisciplinary exchange
of scientific ideas and encouragement of promising young investigators in the field. Building upon a 20-year
track record of diversity, innovation and integration of young scientists and clinicians, we propose an evolution
of the annual University of California (UC) Neurotrauma Symposium into the new Western Neurotrauma
Symposium (WNTS). The Western Neurotrauma Symposium will be a unique regional conference providing an
annual venue for a broad range of neurotraumatology research, with a focus on trainees and early career
investigators, presentation of cutting-edge data in a safe environment, multidisciplinary collaborative ideas and
a more intimate setting to allow direct interactions between attendees. This type of meeting will be instrumental
in developing the next generation of investigators and ideas, without duplicating or replacing opportunities
provided at existing National and International Neurotrauma Symposia. While the focus of the WNTS funding
would be development of regional investigators and collaborators, attendance at the meeting would be open.
The UCNT meeting has a history of fostering diversity and inclusivity and this would continue and be expanded
in the WNTS, with specific outreach and travel awards to encourage active participation of underrepresented
groups in neuroscience/neurotrauma research. The additional support provided by this grant would specifically
permit inclusion of investigators outside of the UC, bringing in research and clinical trainees and faculty from
major programs in western states, for whom travel, expense and time constraints may limit opportunities for
young persons to attend national or international conferences on an annual basis.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury (TBI) is one of the top causes of death and disability worldwide, and one of the most challenging neurological conditions to treat due to its complexity. A multidisciplinary exchange of scientific ideas between trainees and investigators at all levels is therefore necessary to advance our understanding of TBI, and to improve clinical care and public health outcomes. The Western Neurotrauma Symposium (WNTS) builds upon the 20-year tradition set forth by the University of California Neurotrauma Symposium (UCNT), and provides an annual forum for scientists and clinicians from across the western region of the United States with an emphasis on trainees and early career investigators, expanding diversity and inclusivity in the field, collaboration amongst institutions, and presentation of cutting-edge data on TBI.